A Randomized Controlled Trial of a Web-Based Moral Elevation Intervention for Veterans with PTSD

Poor treatment engagement and retention with evidence-based practices (EBPs) are significant problems
for Veterans with posttraumatic stress disorder (PTSD). [Additionally, Veterans with PTSD also face
significant issues with impaired social functioning and diminished quality of life; however, research suggests
EBPs may not full address these other important treatment targets despite their ability to reduce PTSD
symptoms.] These limitations showcase how difficult it is to successfully treat PTSD and highlight the need
for novel, [stand-alone approaches as alternatives to current treatments that can further facilitate trauma
recovery. Accessible and easily disseminated treatments are needed to target ongoing concerns for
Veterans including PTSD symptoms, lower QOL, and poor social functioning.] One approach that is well-
suited to target these issues is a positive psychology-based intervention that focuses on eliciting moral
elevation and its benefits. Moral elevation is a positive, emotional state of feeling inspired or moved by
witnessing others’ virtuous actions, which leads to greater social engagement and self-improvement
motives. Moral Elevation Online Intervention for Veterans Experiencing Distress (MOVED) was previously
developed as a web-based, self-guided intervention (8 sessions; 4 weeks) and piloted with a sample of
Veterans experiencing significant PTSD symptoms and moral injury-related distress. Results from the VA
funded pilot trial suggested MOVED was highly feasible and acceptable by Veterans, it demonstrated high
levels of treatment engagement, and Veterans reported positive treatment outcomes including large
decreases in PTSD symptoms and medium increases in quality of life. Given the promising findings from
the MOVED pilot trial, the goal of this proposed study is to proceed with the next phase of treatment
development for MOVED by conducting a powered efficacy trial with a sample of Veterans [diagnosed with
PTSD for at least one year.] Following recent adaptations to MOVED that were informed by Veteran
feedback from the pilot trial and with input from key stakeholders (researchers, clinicians, and Veterans
with PTSD), a refined version of MOVED will be examined with a randomized controlled trial (RCT). This
RCT will test the efficacy of MOVED compared to a supportive care control treatment in decreasing PTSD
symptom severity, increasing social functioning, and increasing quality of life. The targeted sample will
include 250 Veterans who have a [PTSD diagnosis for at least one year.] Eligible participants will be
randomized to the MOVED condition or a supportive care control condition. Both interventions will be self-
guided, web-based, and will include 8 sessions lasting 4 weeks. The supportive care control treatment will
be a present-centered, nondirective intervention that aims to control for the nonspecific therapeutic effects
of supportive care, whereas MOVED will focus on eliciting experiences of moral elevation, guided reflection
of those experiences, and facilitating the pursuit of weekly behavioral goals related to experiences of
elevation. All participants in both conditions will complete clinician-administered interviews and self-report
measures to assess outcomes at baseline, posttreatment, 3-month, and 6-month follow-up. Additionally,
potential mechanisms of action on treatment outcomes will be assessed at each session including
experiences of moral elevation and treatment adherence. Results from this study will indicate whether
MOVED is a viable treatment that can reduce PTSD symptoms, boost quality of life, and enhance social
functioning; [thus, expanding the number of treatment options available for PTSD care.]

Public health relevance
Despite the availability of evidence-based treatments for PTSD, there are many challenges to successful trauma recovery for Veterans including difficulties starting and completing these treatments [and gaps in fully addressing additional important treatment targets including lower social functioning and quality of life. Alternative, stand- alone treatment options that address a range of outcomes and can be easily accessed are needed to expand the reach of PTSD treatment to Veterans.] One way to address this need is with a positive psychology intervention called MOVED, which has shown promise in a prior pilot study. MOVED is a web-based, self-guided intervention (8 sessions, 4 weeks) that uses moral elevation—feeling inspired by others’ virtuous actions. This clinical trial will test if MOVED leads to decreased PTSD symptoms and increased social functioning and quality of life compared to a generic supportive treatment that does not focus on moral elevation. Results will help determine if MOVED is a useful alternative approach to target trauma recovery among Veterans with PTSD.